Modeling the impact of cervical cancer prevention in Zambia

Project summary
Cervical cancer is the fourth leading cause of cancer death globally and the leading cause of
cancer death in women in 36 countries, including Zambia. The costs of implementing cervical
cancer prevention programs are high. Thus, Zambian health policymakers need to identify the
optimal cervical cancer prevention strategies for their setting. Mathematical models can help
generate such evidence. However, few model-based evaluations have considered the impact of
HIV on cervical carcinogenesis, and no such models are available for Zambia. The proposed
project aims to assist policymakers in Zambia in deciding on the optimal cervical cancer
prevention policy. Specifically, it aims (i) to adapt the openly available HPVsim model to Zambia
using robust estimates obtained through the analysis of Zambia-specific HPV and cervical cancer-
related databases, (ii) to enhance the HPVsim model by adding more detailed information on
cervical cancer stage at diagnosis, and (iii) to generate evidence on the (cost-)effectiveness of
cervical cancer prevention policies using the enhanced HPVsim model.

Public health relevance
Project narrative Cervical cancer incidence rates worldwide are highest in Southern and East African countries such as Zambia, Eswatini, and Malawi. The massive cervical cancer burden in these countries is linked to the high HIV prevalence in the region. The World Health Organization (WHO) cervical cancer screening guidelines released in 2021 strongly suggested that HPV DNA testing should be used as the primary screening test for women living with and without HIV. However, the triage test to be used in women living with HIV is not specified in these guidelines. Mathematical models can help generate evidence on the comparative effectiveness and cost-effectiveness of different screening strategies. This supplement application aims to identify the most (cost-)effective cervical cancer screening and triage strategy for Zambia. The results from the proposed study will inform policymakers in Zambia and guide their decisions on optimal cervical cancer screening practices for their specific context.